PQBP1 as a central regulator of inflammation in neurodegenerative diseases

PROJECT SUMMARY:
Neurodegenerative diseases pose significant challenges to public health and our understanding of brain function.
Central to these conditions is the pathological accumulation of protein aggregates, notably alpha-synuclein, beta-
amyloid, and Tau. Specifically, Tau aggregates are expelled into the extracellular space as neurons degenerate,
where they act as damage-associated molecular patterns (DAMPs) that are sensed by microglia. Microglial
activation leads to inflammatory responses, which contribute to impaired neuronal function and cognitive decline
in diseases like Alzheimer’s Disease (AD). Although various pattern recognition receptors (PRRs) have been
reported to sense Tau, emerging evidence suggests that cyclic cGAMP synthase (cGAS), a DNA PRR, also
plays a crucial role in promoting inflammatory responses. Recent reports suggest that Tau activates the cGAS
pathway, and this would require an initial interaction with an adaptor, Polyglutamate Binding Protein 1 (PQBP1).
In three separate studies, our group has shown a similar requirement for cGAS activation by HIV-1 infection.
PQBP1 decorates HIV-1 capsids and recruits cGAS to the site of HIV-1 DNA synthesis. PQBP1 recruitment to
the capsid is mediated by charge complementation, and its dimerization is required for cGAS activation. We
hypothesize that PQBP1 binding to Tau is necessary for cGAS activation, which contributes to chronic
neuroinflammation in AD and other tauopathies. Building on our experience and reagents from our HIV-1 studies
on PQBP1 and cGAS, we propose to fill major gaps in knowledge regarding the structural requirements of
PQBP1-Tau complex formation and its contribution to cGAS activation. In Aim 1, we will determine the regions
of PQBP1 that are required for the recognition of Tau monomers and fibrils. Further, we will elucidate whether
PQBP1 interacts with exogenous PQBP1 as well as PQBP1 expressed in microglia. In Aim 2, we will
demonstrate that the cGAS pathway is active in human AD brain tissue and is associated with PQBP1 and Tau.
Cellular models will be used to directly show cGAS activation by PQBP1 and Tau. The combined support from
Dr. Chanda and Dr. Timothy Huang will ensure the success of the proposed training plan. Whereas the Chanda
Lab brings innate immunity expertise and reagents, the Huang Lab brings the requisite expertise and reagents
in neurodegenerative disease. As an institute, Scripps Research provides an optimal training environment
through its state-of-the-art doctoral program, core facilities, seminar series, and proximity to other major research
institutes, including Sanford Burnham Prebys, where the Huang Lab is situated. This rich scientific environment
will enable the completion of the proposed studies, which will support the identification of novel therapeutic
modalities to mitigate inflammatory responses and neurodegeneration in humans.

Public health relevance
PROJECT NARRATIVE: Chronic inflammation of the central nervous system is a critical factor in the pathogenesis of neurodegenerative diseases, thus indicating that a myriad of molecular events dysregulate immune cells in the brain. This project will characterize a specific biological mechanism promoting pro-inflammatory pathways during neurodegenerative disease. This information will help the public understand why this immune response contributes to diseases such as Alzheimer’s Disease.